Context-Aware Mobile Intervention for Social Recovery in Serious Mental Illness

PROJECT SUMMARY/ABSTRACT
This experimental therapeutics R61/R33 proposal responds to RFA-MH-18-704. The goal of this project
is to evaluate a new technology-supported blended intervention aimed at reducing social isolation and improving
social functioning in serious mental illness (SMI). Social isolation is common in SMI and leads to morbidity and
limits functional recovery. Unfortunately, few available interventions specifically target social isolation and its
determinants in SMI, which include anxious social avoidance, defeatist attitudes toward interactions, and social
anhedonia. Moreover, intervention development in this area is limited by imprecise measurement of social
interactions, processes, and related constructs. Our new blended intervention, mobile Social Interaction Therapy
by Exposure (mSITE), blends brief in-person psychotherapy with context-triggered mobile smartphone
intervention and remote telephone coaching. mSITE builds on preliminary work indicating that blended mobile
interventions are acceptable and both strengthen and shorten cognitive behavioral intervention. Recent work by
our group and others indicates that contexts, such as being at home or alone, exacerbates social defeatist
attitudes and perceptions of social threat. mSITE is unique in that it uses smartphone sensors (e.g., GPS,
conversation sensing) to trigger intervention content tailored to specific social contexts, such as when home
alone for extended periods or after a social interaction in the community, in order for cognitive and behavioral
interventions to be delivered at the “right place, right time.” In addition, the study will be the first to examine
passive sensing measures as outcomes in a clinical trial in SMI, by deriving objective digital markers of negative
symptoms and social engagement using smartphone sensors (GPS and microphone) to monitor distance
traveled, time spent at home, and conversations. In the R61 phase, we will recruit people with SMI who have
limited social engagement. We will then conduct an open trial of mSITE, evaluating whether the intervention
leads to clinically significant changes in the frequency of social interactions (the target mechanism). We will also
determine the dose of app plus remote coaching necessary to achieve this effect, by evaluating change at 12,
18, or 24 weeks. If go/no go criteria are met (medium effect size increase in social interactions and < 20%
dropout) in the R61 phase, the R33 phase will include a randomized trial contrasting mSITE with a therapist and
device time-equivalent supportive contact (SC) condition. We will evaluate whether mSITE leads to greater
improvement in social interactions, negative symptoms and social functioning relative to SC. We also predict
that increases in social interactions will mediate improvements in experiential negative symptoms and social
functioning. Our project responds directly to NIMH Strategic Aim 3.1, by evaluating a new behavioral intervention
that targets functional improvement and by validating new digital biomarkers for objective measurement of social
processes. Our project is also responsive to the NIMH Digital Health Priority Area by advancing digital
assessment and context-aware mobile interventions, which are designed to be scalable to community settings.

Public health relevance
Narrative Social isolation is common in serious mental illness and has a profound negative impact on recovery. This study evaluates a new technology-supported blended intervention that blends brief in-person psychotherapy with context-triggered mobile smartphone intervention and remote telephone coaching to target an improvement in social engagement. A scalable intervention that reduces social isolation in serious mental illness would have significant personal, societal, and economic impact.